CADA+ (Enhanced Cohort Adjudication Data Annotation)

Project Summary
Data labeling and continuous AI model validation are essential elements in clinical AI projects. This RSE award
will enable the applicant to further develop a scalable and generalizable platform to support labeling of
multimodality data as well as supporting continuous model benchmarking. The design of the platform will be
anchored at first satisfying needs of three active NIH projects that will need support of both structured and
unstructured EHR data, MRI brain scans, and neurophysiological and cardiovascular signals. The applicant will
also collaborate with external collaborators including PhysioNet and OHDSI to ensure the developed platform
can be used to support a wide array of applications from research communities and produce data labels in
standardized terminology. To support continuous model benchmarking, the applicant will integrate
functionalities of an existing application ModelsMeetData(M2D) into the platform to publish AI model cards,
hosting vested AI models, and testing them with labeled data.

Public health relevance
Project Narrative Data labeling and continuous AI model validation are essential elements in clinical AI projects. This RSE award will enable the applicant to further develop a scalable and generalizable platform to support labeling of multimodality data as well as supporting continuous model benchmarking by considering immediate needs of three NIH projects while also ensuring the generalizability of the platform.